Extrinsic regulation of primitive, myeloid-biased hematopoietic stem cells by Semaphorin 4a

ABSTRACT
Despite substantial experimental evidence for the important functional role of myeloid-biased HSC (myHSC) in
stress, inflammation and aging, the mechanisms which control myHSC quiescence and self-renewal are not
known. The long-term goal of this project is to understand how myHSC self-renewal can be regulated by the
bone marrow microenvironment in order to identify novel signaling pathways that can be activated to enhance
hematopoietic regeneration, and blocked if they become dysregulated in myeloid malignancy. The overall
objective in this application is to understand at the mechanistic level how Sema4a, a newly-defined niche
factor, selectively promotes quiescence and self-renewal of myHSC, and to test potential therapeutic utility of
its pro-regenerative effect in clinically relevant models of proliferative stress and HSC exhaustion. The central
hypothesis is that Sema4a is released from osteoprogentiors and endothelial cells in the bone marrow
microenvironment and binds to Plexin D1 on myHSC, which triggers a cascade of inhibitory signals that shield
myHSC from exhaustion, premature differentiation and DNA damage. The rationale for this project is that
identification of Sema4a-induced myHSC-specific pathways and testing their protective effect on myHSC in
pre-clinical models of proliferative stress is likely to offer a strong scientific framework for future therapeutic
strategies to improve myHSC self-renewal and hematopoietic regeneration. The central hypothesis will be
tested under two specific aims: 1) Determine molecular and cellular mechanisms of Sema4a effects on
myHSC; and 2) Define therapeutic opportunities for Sema4a as a myHSC “protector” from proliferative stress.
Under the first aim, genetic mouse models, single-cell RNA Sequencing and intravital microscopy will be used
to evaluate the effect of microenvironmental deletion of Sema4a or its putative receptor, Plexin D1, on myHSC
and to uncover the role of Sema4a as myHSC-specific hematopoietic regulator. Under the second aim, my-
HSC protective properties of Sema4a will be explored in clinically relevant models of functional HSC loss, such
as exposure to cytotoxic chemotherapy and ex-vivo HSC culture during gene modification procedure. The
research proposed in this application is innovative, in candidate’s opinion, because it builds on a novel
discovery of Sema4a as a potent and indispensable regulator of myHSC in vivo, and provides substantive new
experimental evidence for the concept that functionally specialized HSC are controlled by distinct regulatory
circuits. The proposed research is significant because it is expected to serve as a scientific justification for
future therapeutic strategies to improve hematopoietic regeneration following chemotherapy and stem cell
transplantation, enhance engraftment of gene-modified HSC and prevent myeloid bias, age-related HSC
dysfunction and evolution to myeloid malignancy in the elderly.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because health care costs associated with care for elderly individuals suffering from age-related stem cell disorders, such as myeloproliferative diseases or myelodysplastic syndromes, are rapidly increasing. Despite emerging experimental evidence that HSC myeloid bias is as a significant contributor to the pathogenesis of these conditions, it cannot be targeted by currently available pharmacological agents. Our discovery of Sema4a as a specific niche-derived regulator of myeloid- biased HSC will open a new avenue in therapeutics directed at preservation of stem cell function with age and prevention of myeloid disease development. These aims closely align with the NIH SHINE initiative (PAS-19- 105) which is supported by NHLBI and NIDDK.